Precision Medicine in Sepsis with Critical Illness

Abstract
Sepsis is a frequently encountered critical care syndrome leading to 250, 000 deaths annually, making it
one of the leading causes of mortality in the U.S. Despite over 75 randomized controlled trials (RCTs), no
treatments have shown a survival benefit and currently there are no approved therapies for sepsis. The multitude
of negative RCTs has been attributed to the clinical and biological heterogeneity subsumed within the non-
specific clinical definition of sepsis. The failed therapies in the context of vast heterogeneity makes sepsis ideal
for precision medicine-based approaches where targeted therapies are used in biologically-informed subgroups.
Acute respiratory distress syndrome (ARDS) is another critical care syndrome with significant
heterogeneity. In secondary analyses of five ARDS RCTs, we consistently identified two phenotypes, the
hyperinflammatory and hypoinflammatory phenotypes, with divergent clinical outcomes, biomarker profiles and
differential responses to therapies. Crucially, in an RCTs that only recruited sepsis-associated ARDS, the
corresponding two phenotypes emerged again. Our preliminary data, in a separate cohort of 587 patients with
sepsis, also identified these two phenotypes. In this proposal, we will test the hypothesis that the molecular
phenotypes previously identified in ARDS are also evident in sepsis, and that they represent distinct biologic
subtypes characterized by differences in circulating inflammatory responses. Using latent class analysis with a
composite of clinical and biomarker data, we will seek phenotypes in four independent cohorts of sepsis (>4000
patients). We will develop clinically implementable models to classify the phenotypes using previously described
algorithmic pipelines. Heterogeneous treatment effect in the phenotypes will be sought in CLOVERS, a
multicenter RCT comparing fluid resuscitation strategies in severe sepsis. In a prospective cohort, we will study
novel techniques such as next-generation sequencing, mass cytometry and functional immune responses in
stimulated peripheral blood mononuclear cells to better understand the biological and immunological
characteristics of the phenotypes and identify phenotype-specific treatable traits. We will also study the
phenotypes longitudinally to evaluate their temporal stability. This proposal represents an independent niche of
research for my group, which has the requisite experience and expertise to successfully deliver this program.
The culmination of the program will potentially lead to several highly impactful discoveries with important
implications for sepsis care. We anticipate identifying robust and reproducible phenotypes of sepsis in multiple
cohorts, with phenotype-specific response to therapies. We will develop practical models that can identify
phenotypes at the bedside. We will comprehensively map the biological and immunological profiles of the
phenotypes to identify treatable traits that may enable precision-based approaches in sepsis. Finally, the finding
of equivalence of sepsis and ARDS phenotypes would represent a paradigm-changing discovery, leading to a
novel classification system of critical illness agnostic of syndromic diagnosis.

Public health relevance
Narrative Sepsis is commonly encountered and a leading cause of in-hospital mortality. Yet, there are no specific approved therapeutic agents for sepsis. The goal of this project is to identify biologically discrete subgroups in sepsis that may differentially respond to therapies. Through a deeper understanding of these subgroups, we hope to improve patient outcomes by matching appropriate therapies to individual patients.